Puerto Rico Testsite for Exploring Contamination Threats (PROTECT)

PFAS and the impact on human health: From the laboratory to the community
Since 2010, PROTECT (Puerto Rico Testsite for Exploring Contamination Threats)
investigators have studied the effects of hazardous chemicals, commonly found at Superfund
sites, on adverse pregnancy outcomes in women living in the Northern Karst region of Puerto
Rico. The primary chemicals found to be present in the PROTECT cohort of pregnant women
are pesticides, phthalates, bisphenols, triclosan, and triclocarban (Lewis et al, 2014; Ferguson et
al., 2019; Aker et al., 2019).
PFAS (per- and poly-fluoroalkyl substances) are a class of over 12,000 chemicals that
have been manufactured and used in a variety of industries worldwide since the 1940s. There is
evidence that exposure to PFAS is linked with detrimental effects on human health. In pregnant
women, PFAS exposure has been associated with low birth weight (Ashley et al., 2017) and
increased incidence of gestational diabetes, childhood obesity, preeclampsia, and fetal growth
restriction (Szilagyi et al., 2020). Despite the increased number of contaminants studied in
PROTECT, the presence of PFAS in pregnant women, their families, and the general population
in Puerto Rico is unknown. This request for KC Donnelly funding starts to address this need for
more exploratory research.
I am a doctoral student in Social Determinants of Health at the University of Puerto Rico
Medical Sciences Campus. As a member of the PROTECT team since 2019, I am particularly
interested in the effects of hazardous chemicals on pregnancy outcomes. I am also very active in
the Community and Engagement Core and the initiative to provide results of harmful exposures
and follow-up education for risk avoidance to our study participants through the Report Back
program. My project has two Specific Aims, one that will broaden my environmental health
science skills under the guidance of Dr. Jamie DeWitt, a professor in the Department of
Pharmacology and Toxicology at the Brody School of Medicine at East Carolina University. The
second aim is to work with my mentors in PROTECT (Drs. Velez-Vega and Brown) to apply my
newly acquired skills toward the development of an educational program that will enhance our
Report Back initiative to the benefit our study population as well as all communities in Puerto
Rico that need to be informed about the risks of PFAS exposure.

Public health relevance
NOT REQUIRED BY THIS FOA